Neuroanatomic Correlates of Language Production Characteristics After Right Hemisphere Stroke

PROJECT SUMMARY/ABSTRACT
Language production deficits caused by right hemisphere brain damage (RHD) are an underexplored scientific
domain, despite affecting the vast majority of individuals who suffer a right hemisphere stroke. RHD patients
often exhibit self-centered, inappropriate, and impolite language -- deficits that have a significant impact on their
quality of life from personal relationships to employment status. Despite the devastating impact of these
impairments for RHD patients and their families, very fewstudies have been undertaken to understand the nature
of RHD communication differences, especially in comparison to the more obvious impairments observed after
left hemisphere stroke.
The current project addresses two critical knowledge gaps. First, we need a better understanding of what is
wrong with the language produced by RHD patients, and second, we need to understand which right hemisphere
brain areas are associatedwith which particular types of languagedeficits. These gaps will be addressed through
two aims. The first aim will provide a rigorous and quantitative evaluation of the specific features of language
production that are impaired following RHD, via a battery of linguistic production tasks. The second aim will
involve identification of the brain areas within the right hemisphere that are associated with these deficits.
Furthermore, both the behavioral and neural data will be aggregated in the burgeoning RHDBank database
developed by the PI, fostering future work in this area by the scientific community at large.
As PI, Dr. Minga is an early-stage career investigator with institutional support from Duke University. As a K12
award recipient, she has established a diverse mentoring team with expertise in cognitive neuroscience,
neurology, speech-language pathology, and discourse corpus development. Dr. Minga’s career development
plan serves to capitalize on these collaborations through workshops, seminars, and didactic training. The
proposed research contributes to the growing body of knowledge concerning language production differences in
adults with RHD by examining the specific indices of language production characteristics that distinguish adults
with RHD and potential neuroanatomic correlates while building a corpus of imaging and language use samples
for the widespread study of communication after RHD. Delineation of specific and quantifiable characteristics of
language production after RHD and their relationship to lesion site(s) can foster the development of clinically
relevant diagnostic measures and potential therapies.

Public health relevance
PROJECT NARRATIVE Right hemisphere strokes result in language production changes that are different than those found in left hemisphere strokes. Yet, language production after a right hemisphere stroke is less frequently the focus of scientific inquiry. The proposed research is relevant to public health because it will advance knowledge concerning the relationship between locus of lesion and discourse production characteristics needed for the development of measurement, evaluation, and treatment methods for language production deficits after a right hemisphere brain damage (RHD).